REASONS FOR SEEKING DRUG ABUSE TREATMENT

In order to identify factors possibly influencing treatment compliance and retention, 206 applicants for outpatient pharmacological treatment of cocaine or PCP dependence gave self-reported reasons for seeking treatment, using a new questionnaire developed by the P.I. There were significant differences in reasons given between cocaine vs PCP abusers and males vs females. Subjects not motivated by the cost of their drug abuse stayed in treatment twice as long (6 weeks) as those who were motivated by cost. Currently, data are being collected to compare counselors' ratings of treatment motivations with the self-report instrument.